Interdisciplinary Research Training in Otolaryngology and Communication Sciences

PROJECT SUMMARY/ABSTRACT
Continuation of a T32 research training program is proposed, Interdisciplinary Research Training in
Otolaryngology and Communication Sciences, based in the Department of Otolaryngology-Head and Neck
Surgery at the Medical University of South Carolina. Advancing the scientific foundation of otolaryngology and
communication health, improving health outcomes, and developing and testing new treatments requires well-
trained investigative teams with diverse skills and backgrounds in basic and clinical science. The training
program continues to address these needs by supporting research opportunities in the disciplines related to
otolaryngology and communication health, providing strong curricula in an integrative framework, with an
interdisciplinary research culture that emphasizes mentoring, academic advancement, career development,
grantsmanship, diversity outreach, responsible and ethical conduct of research, and productivity. The major
components of our multifaceted program are: (1) predoctoral research training leading to PhD degrees in
Biomedical Sciences or Health and Rehabilitation Science, with applications to otolaryngology/communication
health; (2) research training for medical students who take the “year-out” option to extend their education with
one year of research training; (3) short-term research training for health professional students with interests in
otolaryngology and communication disorders (including medical, dental, pharmacy, nursing, audiology,
speech-language pathology); and (4) postdoctoral research training for MD physician-scientists and PhD
scientists in basic, translational, and/or clinical sciences related to otolaryngology/communication health. Each
of these components is supported by highly collaborative mentors who direct active, funded research
programs; interdisciplinary research collaborations and specialized training in a broad spectrum of research
fields relevant to otolaryngology and communication health; and an exceptional institutional infrastructure and
research culture provided by multiple departments, colleges, and universities. Mentoring expertise,
technologies, and resources are thematically grouped in strategic areas of research focus: (1) basic and
clinical research in otolaryngology sciences and disorders, (2) basic and clinical research in communication
sciences and disorders, (3) basic and clinical neurosciences related to otolaryngology and communication
health, such as development, cognition, aging, and neurobiology, and (4) biostatistics and health services
research. Integrative activities include Otolaryngology and Communication Health Scholars Day, Seminars,
and Journal Clubs, and didactic courses designed for our trainees. A history and record of interdepartmental
collaborations and collegiality among researchers in disciplines related to otolaryngology and communication
health is a key factor that led to early and ongoing success for our training program as evidenced by
exceptional trainee accomplishments at all levels. Equally important is the long-standing culture of support,
value, and enthusiasm for research training by the leadership of participating departments and institutions.

Public health relevance
PROJECT NARRATIVE There is a current and growing public health need for well-trained basic and clinician scientists, and physician scientists, to conduct research in otolaryngology and communication health to increase the science knowledge base and improve prevention, diagnosis, and treatment of disorders that decrease the lifespan and quality of life of men and women of all ages. This grant supports the continuation of Interdisciplinary Research Training in Otolaryngology and Communication Sciences, an integrated program based in the Department of Otolaryngology-Head and Neck Surgery at the Medical University of South Carolina. The goal is to provide mentored research opportunities in the disciplines related to otolaryngology and communication health, and the tools to become independent investigators and effective research team members whose work will increase understanding of mechanisms underlying these disorders and improve health outcomes.